Cellular and Molecular Biology Core

PROJECT SUMMARY: CELLULAR AND MOLECULAR BIOLOGY CORE
The Cellular and Molecular Biology Core provides essential equipment and support for molecular biology, cell
culture, histology, and virology. Importantly, the Core contains a number of specialized instruments that are
either too costly for individual investigators, necessary but infrequently used, or require skilled assistance to
use. The goals are to provide facilities, expertise, and services for: 1) establishing, expanding, and maintaining
primary cells, stem cells, and transformed, transfected, and inducible cell lines as well as organ cultures for
use in vision research, 2) performing cellular and molecular biology experiments for ophthalmic research that
require use of specialized instrumentation, 3) assisting and coordinating experiments that involve cell culturing,
transfection, viral packaging, primer design, cloning, construction of mammalian and viral vectors, flow
cytometry, laser capture microdissection, DNA sequencing, real time PCR, DNA/microRNA microarray,
Luminex, proteomics, and protein analyses, and 4) assisting in histologic and morphological studies of tissue
specimens and cultured cells.

Public health relevance
NARRATIVE: CELLULAR AND MOLECULAR BIOLOGY CORE The Cellular and Molecular Biology Core provides facilities, equipment, and support for cellular and molecular biology to augment research capacity and increase productivity of investigators.